Discovery and Engineering of RiPP Natural Products

My group studies the genomics, enzymology, structure-function, and engineering of
ribosomally synthesized and post-translationally modified peptides (RiPPs). Roughly 50
molecular classes of RiPPs have been described, defined primarily by the type of modification(s)
installed. RiPPs are biosynthesized from a bipartite precursor peptide with distinct regions for
enzymatic recognition and modification. The physical separation of the substrate specificity and
enzymatic modification sites renders RiPPs attractive for the facile evolution of new functions, a
strategy already seized by Nature. In learning how to leverage RiPP biosynthesis for various
biomedical applications, we discovered a widespread protein domain used by most prokaryotic
RiPP pathways to engage the substrate peptide. Coupled with our AI-based tool RODEO, which
identifies the often short, hypervariable, and unannotated precursor peptides, we have redefined
RiPP genome-mining, illuminated tens of thousands of biosynthetic gene clusters hiding in plain
sight, accessed the mature products from scores of pathways, identified robust enzymes for
pathway engineering, discovered new enzymatic reactions, and in some instances, predicted
enzymatic function. This MIRA application builds on these past achievements and proposes
several new innovative directions for our research program.
While the pace of genome sequencing accelerates, much of the data remains inaccessible
to experimentalists with limited bioinformatics knowledge. Undoubtedly locked away in the Whole-
Genome Shotgun database with little/no gene annotation are sequences from metagenomic and
microbiome studies that encode countless undiscovered RiPPs formed via entirely new
enzymatic transformations. To mine this vast, untapped resource, we are developing
MetaRODEO. From the resulting datasets, we will validate the algorithm by experimentally
characterizing new classes of RiPPs that are formed via unprecedented enzyme chemistry. As
per our past practices, the tool and all datasets will be publicly available. Additionally, this project
will elucidate the mechanistic enzymology that guides known and newly discovered RiPP
biosynthetic pathways. Lasso peptides, for instance, are RiPPs distinguished by a knotted
architecture and remarkable heat and protease stability. We wish to understand the molecular
gymnastics performed by lasso cyclases that kinetically trap lasso peptides in their threaded
rotaxane conformation. Inspired by their natural diversity and disparate functions, we will exploit
our knowledge of lasso peptide biosynthesis to perform structure-guided and directed-evolution
studies to engage desired biological targets with high affinity and specificity.

Public health relevance
Project Narrative: Douglas A. Mitchell, Ph.D. Natural products are highly evolved molecules with useful biological functions and fascinating chemical structures. These molecules have inspired generations of organic chemists, aided in the elucidation of fundamental life processes, and served as the most significant source of lead material for drug discovery. We mine bacterial genomes to discover new natural product structures and enzyme chemistry with current efforts seeking to engineer the biosynthetic pathways to produce new-to-nature materials of enhanced biomedical value.